The cognitive and neural mechanisms supporting naturalistic dyadic social interactions

Project Summary / Abstract
Social interactions are key to well-being. When successful, interactions engender social bonds that reduce
stress, loneliness, and depression, and that support longevity. This proposal aims to identify the mechanisms
by which social interactions produce social connection. Two studies use state-of-the-art tools in computer
vision, natural language processing, and fMRI hyperscanning–where two people are scanned at the same
time–to peer into the minds of people as they interact in real time.
This project focuses on naturalistic interactions. To date, neuroscience research into social interaction has
relied primarily on paradigms that do not actually allow people to interact. The current proposal offers a shift
from these conventional paradigms. We will leverage rich data from real-time conversations to investigate two
conversation features—social content and positive affect—that may effectively support social connection. We
test the direct relation between these conversation features and social connection in Aim 1. Aim 2 will then test
the hypothesis that these features promote connection by helping conversation partners to get ‘on the same
page’—to align their thoughts and feelings. We will measure alignment using fMRI hyperscanning.
Study 1 will use a unique virtual video conversation platform that connects two remote communicators. Dyads
will freely converse while we record real-time acoustic, visual, and language data, from which our analysis
tools can automatically extract both conversation features. Participants will also complete a post-conversation
survey to assess the primary outcome: social connection. We will use factor analysis and cross-validation to
optimally cluster our multimodal features and to optimize our model of how conversation features induce
alignment, which, in turn, supports social connection.
Study 2 aims to replicate this behavioral model, and further, to identify the underlying mechanism that links
conversation features to social connection using neuroimaging. If conversation brings about social connection
because it induces alignment, then we should see that socially connected dyads experience neural alignment
within networks associated with both content and affect: the default and limbic networks, respectively. Our
unique research site, with two MRI scanners in adjacent rooms, allows us to use fMRI hyperscanning and
high-resolution imaging of cortical and subcortical neural networks, a resolution far beyond what is possible
with methods typically employed for studying naturalistic interactions.
The proposed investigation into the real-time dynamics of interactions will assess how communication syncs
minds, and how this alignment supports social connection. This work will reveal the basic ingredients of
successful interactions. In doing so, it offers promising future directions for alleviating the devastating effects of
social disconnection, as felt by healthy populations during moments of stress or social distancing during the
Covid-19 pandemic and by vulnerable populations with depression, social anxiety, or autism.

Public health relevance
Project Narrative Social interactions are key to people’s well-being, as they engender social connections that reduce stress and support longevity. This proposal will use state-of-the-art tools in computer vision, natural language processing, and fMRI hyperscanning to explore the dynamic cognitive and neural processes that result in social connection. This knowledge can be used to help amplify social connection, and to alleviate the devastating effects of social disconnection, as felt by healthy populations during moments of stress and social distancing during the Covid-19 pandemic, and by more vulnerable populations with depression, social anxiety, or autism.